Functional consequences of evolutionary innovation in histone repertoires

PROJECT SUMMARY
Histone proteins package DNA into chromatin and regulate all DNA-templated biological processes in
eukaryotes. Consistent with their essential function, mutations or misregulation of histones result in many
diseases. While core histones primarily function in genome packaging, histone variants can replace canonical
histones at unique genomic locations for specialized roles such as DNA damage response (DDR) or gene
expression. Despite their essential functions, histone repertoires have undergone distinct lineage-specific
changes. Such evolutionary novelty via gene fusions, duplications or sequence divergence is unexpected in
conserved protein families and suggestive of an adaptive advantage for sequence innovation. This proposal
will use evolutionary innovations in eukaryotic histone H2A repertoires to investigate the causes and
consequences of evolutionary turnover of histone proteins. The most common eukaryotic H2A repertoire is
made up of core histone H2A, and histone variants H2A.X and H2A.Z that are involved in DDR and gene
regulation, respectively. However, two evolutionary shifts, both likely selectively advantageous, have occurred
in yeast and Drosophila H2A repertoires. In yeast, H2A.X, entirely replaced canonical H2A, likely improving
DDR and affecting processes like meiosis that depend on DDR. In Drosophila, H2A.X fused with H2A.Z giving
rise to a unique H2Av variant. This fusion enriches DDR at heterochromatin which potentially restricts DDR-
based transposition events to gene poor regions. To identify functional consequences of these evolutionary
innovations, the applicant will re-engineer the ancestral eukaryotic H2A repertoire in yeast and flies.
Specifically in S. cerevisiae, the applicant will engineer a core H2A and two variants H2A.X and H2A.Z,
preventing H2A.X from being the core histone (Aim 1). In D. melanogaster, the fusion histone H2Av will be
separated into H2A.X and H2A.Z uncoupling DDR and gene regulation functions (Aim 2). Changes to
organismal chromatin packaging, and relevant biological functions including DNA repair, meiosis, fertility, and
transposition will be interrogated. In Aim 3, the applicant will apply tools learnt in Aims 1 and 2 to study
divergence of eukaryotic core H2A. Histones have tail sequences which are heavily post-translationally
modified and play crucial roles for higher order chromatin packaging and protein interactions. The high
sequence divergence across eukaryotic histone tails suggests that tails could facilitate unique lineage-specific
functions. By engineering different tail sequences in yeast and flies, Aim 3 will reveal changes to chromatin
packaging, and changes to processes such as mating, and quiescence in yeast, and fertility and development
in flies. To launch this work, the applicant requires training in genetics, genomics, and phenotypic assays in
two model organisms, yeast and flies. By leveraging, her expertise in evolutionary analyses and the power of
well-established tools in yeast and flies simultaneously, in the future the applicant will study the biological basis
and consequences of histone innovation including her own previous discoveries and co-evolving mechanisms.

Public health relevance
PROJECT NARRATIVE Eukaryotic histone proteins are fundamental to all biological processes and were historically thought to be highly conserved. However, histones proteins can be subject to evolutionary turnover in the form of gene duplications and dramatic sequence divergence in multiple eukaryotic lineages suggesting adaptive advantages. This proposal uses yeast and flies to investigate the fitness advantages of unique eukaryotic histone repertoires for two crucial functions – genome regulation and DNA damage response.